Optimizing Health and Well-Being of Diverse Mothers with IDD and Their Infants During the Perinatal Period: A Virtual Advocate Tool for Data-Driven Supports

Abstract
Women with intellectual and developmental disabilities (IDD) face a plethora of structural and systemic factors
in the perinatal period that can compromise maternal health, emotional well-being, and parenting capacity, which
can threaten infant health and well-being. These mothers are often excluded from intervention development and
efficacy studies that target maternal emotional well-being and parenting and when attention is given to parenting,
it tends to be negatively focused. This negative focus is driven by a stigmatizing assumption of limited capabilities
of these women to parent their children. Moreover, given structural and systemic biases driven by this nation's
history, mothers of color with IDD are disparately impacted by stigmatization and implicit bias, further lessening
the efficacy of their voice to positively advocate for their and their infant's health. These stigmatizing beliefs are
not limited to women with severe disabilities but are pervasive for women with mild and moderate intellectual
and cognitive developmental disabilities including women with Down Syndrome.4 To counter stigmatizing
assumptions and the intersection of race and disability, the current study seeks to develop and pilot test the
foundation for a professional/paraprofessional advocate virtual tool to support the health and well-being of
diverse mothers with intellectual(cognitive) disabilities and their infants, including mothers with Down's
Syndrome. The tool is for use with mothers across the perinatal period, beginning prenatally through first year
postpartum. The development process (Aim 1), designed to ensure the virtual tool represents the voices of
diverse mothers and advocates, is informed by 15 advocates and 15 mothers, each group equally representative
of Black, White and Latina culture/identity. Through iterative focus groups and content analysis, the developed
tool will allow advocates to a) efficiently collect a broad spectrum of key indicators of health and wellbeing within
the domains of Cultural Strength, Maternal Emotional Wellbeing, Maternal Health, Maternal Positive Parenting;
b) produce a summary profile of concerns for each mother; and c) produce a suggested support plan based on
each mother's health and wellbeing profile. The app will contain 4 prototype health and wellbeing sessions for
mother linked to key indicator domains. Advocates will provide sessions to mothers according to her support
plan. The Aim 2 pilot study uses a structured, mock-mother approach with 15 diverse advocates, who will each
implement the virtual tool with 3 mock mothers representing varying levels of health and wellbeing and perinatal
phase (prenatal, 4th trimester, 5+ trimester). Advocate feasibility, acceptability, and implementation fidelity will
be assessed; information gained will inform Phase 2.

Public health relevance
Project Narrative This application addresses an important public health issue for reducing perinatal disparities for diverse women with mild to moderate IDD and their infants. We will develop and pilot a virtual menu-driven app system that will allow professional/paraprofessional advocates for these mothers to (a) collect key indicators of mother-infant health and well-being, and (b) use a data-driven decision system based on a summary of key indicators to support advocates in targeting concerns and remotely delivering evidence-based supports to strengthen mother- infant health and well-being.